Dissecting a novel tumor-promoting axis in cholangiocarcinoma

There is an urgent need to identify effective treatments for intrahepatic cholangiocarcinoma (CCA), a highly
desmoplastic tumor of the bile ducts with a five-year survival rate of 5%. Over half of iCCA cases are diagnosed
after metastases are present, when treatment choices are limited and minimally effective. The long-term goal of
our work is to identify novel therapeutic interventions to improve outcomes for this devastating malignancy. This
proposal leverages our exciting preliminary data suggesting that the immune checkpoint protein B7-H4 is over-
expressed in more than 60% of iCCA cases where, in addition to its known T cell immunosuppressive role
mediated by its membrane-bound form, it exerts a critical role in the control of tumor growth and stromal
deposition through a previously unknown cooperation of its intracellular form with the TGFβ pathway. Genetic
ablation of B7-H4 in murine models generated by the co-expression of Notch1 intracellular domain and activated
Akt1 (Nicd1/Akt1) using sleeping beauty transposon/transposase and hydrodynamic tail vein injection (HTVI)
significantly prolongs survival and profoundly alters the surrounding desmoplasia. Mechanistically, B7-H4 over-
expression increases the levels of the docking receptor for latent-TGβ1, GARP, and thus promotes the release
of active TGFβ1 and activation of the downstream SMAD2/3-dependent pathway. We herein propose three aims
to validate our hypothesis that, through activation of the TGFβ pathway, B7-H4 shapes a unique desmoplastic
response and promotes tumor growth of iCCA, so that pharmacologic inhibition of this cross-talk will contribute
to tumor inhibition through several complementary ways. In Aim 1, we will dissect the molecular mechanisms
through which B7-H4 promotes cancer cell growth and motility by performing in vitro functional studies in iCCA
cell lines (murine and human) and patient-derived organoids upon genetic manipulation of the B7-H4/TGFβ axis.
Furthermore, we will unveil the full interactome of intracellular B7-H4 and its exact subcellular localization. In
Aim 2, we will clarify how the newly identified axis shapes the desmoplastic reaction, immune infiltration and
composition, and instructs other cell types, particularly cancer-associated fibroblasts, to deposit and organize
collagen, in the genetically versatile HTVI-based Nicd1/Akt1 mouse model, which - as supported by our
preliminary data - highly resembles human iCCA with endogenous expression of B7-H4. In Aim 3, we will assess
the efficacy of pharmacologically modulating the B7-H4 axis using clinically-relevant drugs blocking TGFβ1 and
other identified vulnerabilities in combination with a monoclonal antibody directed against B7-H4 in genetic and
orthotopic murine models . Here, by combining our large collection of cell lines/organoids, human samples,
mouse models with single cell-based approaches and a single-fiber artificial intelligence-based platform, we will
dissect a previously unknown B7-H4/TGFβ cross-talk and yield new insights into iCCA biology. The proposed
research is highly significant since its successful completion would establish the B7-H4 axis as a novel target for
iCCA therapy that could improve the clinical outcome of this deadly cancer.

Public health relevance
A thorough understanding of the underlying biology of intrahepatic cholangiocarcinoma (iCCA) is critical for the development of effective therapies for this highly lethal form of hepatobiliary cancer. Our preliminary studies have identified a novel B7-H4-regulated signaling axis that profoundly alters the desmoplastic reaction, a prominent feature of this cancer type, and contributes to tumor growth. We propose to elucidate the molecular mechanisms underpinning this entirely novel tumor-stromal cross-talk and advance our understanding of how to treat patients afflicted by iCCA and possibly other B7-H4-driven malignancies.